Single nuclei transcriptome profiling in addiction circuitry of the HIV+ brain

HIV-associated neurocognitive disorders (HAND) persist in the era of combination antiretroviral
therapy (cART). HIV latency, and cell-specific expression of HIV transcript in human CNS remains
incompletely understood, despite continued high prevalence of HIV-associated neurologic disease and
increasing recognition of CNS viral escape in people stably suppressed with cART. Issues of CNS
functional deficit are further complicated by the co-registered epidemic of opiate and other substance use
disorders (SUD) in people living with HIV/AIDS (PLWHA), as SUD also have profound impact on CNS
function, and potentially on HIV latency. Nowhere in the CNS is this more evident than in the neuroanatomic
overlap of HIV and SUD in striatonigral dopaminergic circuitry and its cortical projection areas including the
anterior cingulate cortex, sites of predilection for functional and neurobiologic disease as well as for
increased burden of HIV infection. Accordingly, directly utilizing brain tissues in these regions, from
neurologically well-characterized HIV-infected individuals with and without SUD, the goal of this application
will be to explore whether HIV signatures in transcriptomes in dopaminergic circuitry i n c l u d i n g
c i n g u l a t e t a r g e t s is associated with prospectively monitored neurological status in the years before
death and exposure to drug of abuse; (iii) explore HIV expression in potential reservoir cells of the brain,
including microglia. The innovative experiments proposed here are expected to offer novel insights into
transcriptomic landscapes in specific brain cells and explore potential links between neurogenomic status
of the infected brain and neurological and cognitive symptoms and substance abuse. While recognizing
the high-risk aspects, these analyses will nevertheless have predictable, high gain benefits in
understanding the complex neurobiology underlying HIV-associated CNS disease in PLWHA and SUD.

Public health relevance
Little is known how HIV affects the brain in the era of combination antiretroviral therapy, and how drug abuse, including cocaine and opiates, could be detrimental to the HIV infected brain. Our project, using human tissues from the Manhattan HIV Brain Bank, will explore gene expression programs in single brain cells and neural circuits of the HIV infected brain in the context of opiate or cocaine abuse.